DRUG BINDING TO DNA

Our long range goal is the design and synthesis of organic molecules which bind to specific DNA sequences. Our first immediate subgoal is to characterize the solution structure of a new DNA conformation we have discovered, a dinucleotide repeat structure which is induced by binding certain steroid diamines (which we have synthesized) to poly(dA-dT). Using NMR and CD to probe DNA conformation we will synthesize new ligands to see what structural features of the steroid diamine promote conformational change in poly (dA-dT). We will chemically synthesize small DNA oligomers to discover what sequences can exist in this new conformation, using NMR to obtain details of the drug-DNA solution structure. We will enzymatically make DNA with alternating phosphate and phosphothioate diester backbones (eq. ApTp(s)...) to see which phosphorous, the d(ApT) or the (TpA) goes over to a new conformation in poly (dA-dT). We will also compare the reactivity with alkylating agents of B-form poly (dA-dT) and our alternating form. We also propose to synthesize new linked drugs containing netropsin and anthramycin fragments. These linked groove binders should exhibit unprecedented sequence selectivity by a synthetic molecule. We will assay selectivity by the drug's differential inhibition of site selectivity of particular restriction enzymes.